RIBOSOME SYNTHESIS CONFERENCE

Ribosomes were among the first complex cellular components to be studied from a regulatory viewpoint. As our knowledge of the regulation of ribosome synthesis has increased, we have come to understand that ribosome synthesis involves the regulation of numerous processes, including transcription, RNA processing, RNA-protein interaction, and nucleo- cytoplasmic communication. Furthermore, the synthesis of all the ribosomal components is coordinated and balanced with the production of many other cell constituents. It is clear that the study of the synthesis of ribosomes is very important in its own right. In addition, the regulation of ribosome synthesis impacts on the synthesis of virtually every other cellular component, and responds to (or perhaps is a central component of) the as yet poorly elucidated regulatory networks which control cell growth, proliferation, and development in response to external stimuli. The study of ribosome biosynthesis may therefore be one of the most promising approaches to an understanding of these larger regulatory networks. The molecular mechanisms which regulate ribosome synthesis have recently been partly elucidated in a few organisms, but many key elements of how regulation occurs remain either unclarified or undiscovered. New vitality has been injected into the field both by modern genetic and biochemical methodologies and by broadening the field to include a diverse set of organisms, each with some common and some unique characteristics of ribosome synthesis. This has led to rapid progress, but also to some fragmentation of the field. The objective of the "Ribosome Synthesis" meeting is to bring together researchers working on aspects of ribosome synthesis ranging from transcription to assembly, in both prokaryotic and eukaryotic ribosome synthesis. We hope that the integration of all aspects of ribosome synthesis will motivate each participant to reflect on the place of his or her work in the overall process and thus foster the interchange of ideas that will serve to focus models of ribosome synthesis in all species.